Rhinovirus, airway smooth muscle, and mechanisms of irreversible airflow obstruction

Project Abstract:
Rhinoviruses (RV) have been impugned in the development of asthma and are the leading cause of acute
asthma exacerbations. RV exposure evokes inflammation of the airways, but how RV modulates human airway
smooth muscle cell (HASM) function to alter bronchomotor tone is unclear. HASM is the pivotal cell modulating
airway tone, shortening in response to contractile agonist stimulation through increases in intracellular calcium,
through activation of Rho kinase, and through modulation of actin dynamics. We previously showed that RV
exposure evokes AHR in human precision cut lung slices (hPCLS), increases [Ca2+]i in HASM, and increases
agonist-induced phosphorylation of myosin light chain in HASM from human airway epithelial cell (HAEC)/HASM
co-cultures stimulated with RV-C15. We also demonstrate that RVC exposure attenuates β2 agonist-induced
bronchodilation in hPCLS, cAMP production in HASM, and attenuates bronchodilator-induced reversal of HASM
contraction. Our preliminary data shows that TFF3, and other inflammatory mediators, are released from HAEC
and hPCLS following exposure to RVC, and that TFF3 attenuates bronchodilation of human small airways and
production cAMP in HASM in response to bronchodilators. Furthermore, our data demonstrates that inhibition of
TFF3 and putative TFF3 receptors can reverse RV-C15-induced attenuation of bronchodilation. Therefore, we
posit RV-C15 modifies signaling mechanisms modulating bronchomotor tone in HASM through a TFF3-
dependent mechanism, thereby altering responsiveness of the airways to bronchodilators. We also show that
signaling downstream of Gαs-coupled receptors is attenuated in HASM following exposure to RV-C15-
conditioned HAEC media. We propose a central hypothesis that RVC exposure of HAEC attenuates β2
agonist-induced bronchodilation via modulation of Gαs-coupled receptor function via TFF3-dependent
mechanisms. We will utilize HASM cells, air-liquid interface-differentiated HAEC, and hPCLS to examine the
aims of this proposal. In Aim 1, we will determine how RV exposure modulates Gαs-coupled receptor-induced
signaling to attenuate bronchodilator-induced airway/HASM relaxation and how asthma alters these
mechanisms. Aim 2 will examine how RV-C15-induced TFF3 release attenuates agonist-induced
bronchodilation/relaxation of HASM and how asthma alters these mechanisms. Utilizing primary HAEC/HASM
co-cultures and an ex vivo system of human small airways, we will delineate signaling pathway alterations
regulating bronchomotor tone that can be targeted in the treatment of RV-induced exacerbations of asthma to
restore bronchodilator responsiveness.

Public health relevance
Project Narrative: Rhinovirus-induced exacerbations of asthma represent a significant health burden to children and adults, and pose a significant challenge in controlling and preventing asthma-related deaths. The molecular mechanisms by which rhinovirus decreases efficacy of current therapeutics used to treat asthma and exacerbations of the disease are unclear. Current asthma therapies dampen inflammation, and/or promote opening and reduce bronchoconstriction of airway smooth muscle that modulates tone of the airway. Our preliminary data suggests that rhinovirus exposure of epithelial cells that line the airways results in decreased bronchodilator responses in airway smooth muscle. Our proposal aims to identify novel therapeutic targets to reverse rhinovirus-induced hyposensitivity to bronchodilators, that when given with current bronchodilators would thereby allow these therapeutics to work more effectively in treatment of virus-induced asthma exacerbations.